Community Services Navigation to Advance Health Equity in Breast Cancer Screening

Project Abstract
Community Services Navigation to Advance Health Equity in Breast Cancer Screening
Persistent inequities in breast cancer outcomes can be traced in large part to inequities in breast cancer
screening follow-up care among underserved women. While U.S. breast cancer mortality rates have decreased
approximately 2% per year since 1990, socially and economically disadvantaged women have experienced
increasing breast cancer mortality over that time. Many of these deaths are preventable. Mammography is
evidence-based screening that, when fully implemented with appropriate follow-up care, improves outcomes
for millions of women who are screened each year.
Many services, including financial coverage, exist to improve breast screening rates among underserved
women. Now, to address health disparities and promote health equity we must remove persistent barriers to
appropriate follow-up of abnormal screening exams – the point of care with the most potential impact to
decrease late-stage disease and mortality. Women with a higher burden of social needs (e.g., for food,
housing, utilities, transportation), are about half as likely to follow-up after an abnormal mammogram than
women who experience minimal social needs. There is a critical need to implement programs that will help
women overcome barriers to follow-up, including access to community service resources, which is a known
barrier.
The SINCERE intervention, a validated screener and referral process for social needs (e.g., for transportation,
housing, utilities, food), was found in our prior studies to be feasible and acceptable in Emergency Department
settings. Building on this prior work, we now propose to adapt and extend the implementation of this
intervention by adding community services navigation – an active outreach intervention to connect breast
screening patients with social services. We aim to address the needs of underserved women that act as
barriers to follow-up of abnormal breast screening and reduce breast cancer disparities.
Our overarching objective is to improve health equity, and the goal of this study is to evaluate if adding
community services navigation to the standard referral process for social needs is an effective and scalable
strategy for addressing disparities in follow-up to abnormal breast cancer screening results. With statewide
community service providers, existing health information technology, and validated methods, we will determine
the effectiveness of social needs referrals combined with a community services navigation intervention in the
screening mammography setting to improving breast screening outcomes in underserved women.
We expect that outreach to underserved women, who represent a large proportion of late-stage and higher
mortality breast cancers, will improve breast cancer screening follow-up and outcomes for underserved
women.

Public health relevance
Project Narrative The overarching goal of our proposed project is to address health inequities in breast cancer screening follow- up among underserved women. We will test whether a community services navigation intervention for women with abnormal results after routine screening mammogram improves follow-up. Outreach to underserved women, who represent a large proportion of late-stage and higher mortality breast cancers, will result in improved follow-up to breast screening leading to improved breast cancer outcomes and decreased health disparities.